New Applications of Neuroplasticity Biomarkers in Veterans with Traumatic Brain Injury or Schizophrenia

Veterans with cognitive deficits represent a substantial service and financial burden at the Veterans
Administration (VA). Importantly, even with treatment, these Veterans have severe problems with community
integration, defined as the ability to return to full participation in major life roles (e.g., competitive employment,
school) and supportive social/family networks. Two of the most prominent patient groups within the VA who
have cognitive deficits and poor community integration are those with schizophrenia (SCZ) and traumatic brain
injury (TBI). There is strong evidence that both disorders are associated with impaired neuroplasticity, which is
a key cellular mechanism of cognition. Importantly, several specialized psychosocial and neurostimulation
(e.g., tDCS) treatments that target neuroplasticity and cognition have recently emerged. New neuroplasticity-
focused interventions that improve the cognitive deficits that lead to poor community integration in SCZ and
TBI would highly valuable for the VA healthcare system. However, to evaluate the efficacy of this novel
intervention approach, we need objective biomarker measures that validly assess neuroplasticity and are
appropriate for use in clinical trials in these populations. These tools currently do not exist. This proposal is
designed to address this key treatment development prerequisite. This proposal will adopt a translational
approach and use neuroscience-based methods to objectively assess non-invasive neuroplasticity measures
in Veterans with cognitive disorders (schizophrenia and TBI) and examine relationships to behavioral
measures of cognition and community integration.
Given the highly novel application of these electroencephalography (EEG) measures of neuroplasticity to the
study of SCZ and TBI, we selected the SPiRE small pilot project mechanism. The research aims for this project
are to measure short-term (STP) and long-term potentiation (LTP) using non-invasive EEG to: 1) evaluate the
feasibility of recruiting Veterans with cognitive deficits (TBI and SCZ), examine tolerability of the EEG-based
neuroplasticity measures, and optimize the paradigms, and 2) evaluate the statistical properties of the
neuroplasticity measures, a necessary step to determine whether they will be acceptable to serve as
biomarkers. In an exploratory aim, we will evaluate the relationships between the neuroplasticity measures and
cognition and community integration. We will utilize paradigms translated from neuroscience studies to
objectively assess neurophysiological measures of neuroplasticity. In the proposed 2-year study we will recruit
a total of 75 Veterans, (25 with schizophrenia, 25 with TBI, and 25 healthy Veterans without cognitive deficits)
from the VA Greater Los Angeles Healthcare system.
By identifying the role of neuroplasticity as a key determinant of cognition and community integration in
Veterans with cognitive disorders (i.e., schizophrenia or TBI), we will address substantial knowledge gaps in
the root causes of poor community integration in Veterans that make very heavy treatment and financial
demands on the national VA system. This project will help assess objective biomarkers of neuroplasticity that
can be used to gauge the efficacy of interventions targeting cognition in future studies. The results from this
study will help guide interventions that ultimately are aimed at improving community integration in Veterans
with cognitive disorders.

Public health relevance
This proposal will examine non-invasive, in vivo EEG-based measures of neuroplasticity (the brain’s ability to alter its function or structure in response to changes in the environment or novel experiences) in Veterans with schizophrenia (SCZ) or traumatic brain injury (TBI). Despite the vastly different etiologies of these disorders (SCZ is a neurodevelopmental disorder; TBI is acquired), both have impaired cognition which is linked to poor community functioning and integration. Our understanding of the root causes of complex cognitive impairments remains limited. Neuroplasticity is a fundamental brain process that underlies cognitive functioning making it a very attractive area for clinical investigation as it provides a basic mechanistic understanding (at the cellular and neural levels) of what causes cognitive dysfunction in TBI and SCZ. The current application is the start of a systematic research program dedicated to understanding the mechanisms contributing to poor cognition in TBI and SCZ, and examine objective biomarkers of neuroplasticity that can be applied to future interventions.